A Randomized Controlled Trial of the Bruthas Project

DESCRIPTION (provided by applicant): African American men who have sex with men and women (AAMSMW) are at particular risk for contracting and transmitting HIV, and represent a priority population for developing effective interventions. Despite the urgent need for effective prevention approaches for AAMSMW, to our knowledge no evidence-based HIV interventions have been developed and tested for this population. The proposed study is a randomized controlled trial of the Bruthas Project, an individual-level HIV prevention intervention, which builds on standardized HIV counseling and testing. Delivered in a series of four sessions by trained African American male counselors, the BP focuses on reviewing HIV transmission routes for male and female partners, strengthening sexual communication skills with both male and female partners, and improving condom use skills and other safer sex negotiation strategies. A randomized controlled trial of BP is necessary to determine the efficacy of the intervention and can lead to improved public health efforts at reducing HIV risk behavior among AAMSMW and in the African American community more generally. To evaluate the effect of the BP, we will recruit and enroll a cohort of 400 AAMSMW who will be randomly assigned to either the intervention condition, in which they will be offered BP, or to the comparison condition, in which they will receive standardized HIV testing and counseling with referral to case management. We will follow the cohort over 9 months and will assess participants at three time points: baseline, 3 months follow-up, and 6 months follow- up.

Public health relevance
PUBLIC HEALTH RELEVANCE: The need to respond to the HIV epidemic in the African American community is a national public health priority. Men account for more than half of HIV infections among African Americans. We have worked diligently over the past four years to develop a HIV prevention intervention for African American men who have sex with men and women (AAMSMW), the Bruthas Project. No controlled intervention studies to date have proven to be effective in significantly lowering HIV-related risk behavior for AAMSMW. Given the urgency of the epidemic among African Americans in general, and African American MSM in particular, a large scale randomized controlled trial is urgently needed to test the efficacy of this promising HIV prevention intervention for these men, and if it is found to be effective, to move it quickly into practice. Narrative The need to respond to the HIV epidemic in the African American community is a national public health priority. Men account for more than half of HIV infections among African Americans. We have worked diligently over the past four years to develop a HIV prevention intervention for African American men who have sex with men and women (AAMSMW), the Bruthas Project. No controlled intervention studies to date have proven to be effective in significantly lowering HIV-related risk behavior for AAMSMW. Given the urgency of the epidemic among African Americans in general, and African American MSM in particular, a large scale randomized controlled trial is urgently needed to test the efficacy of this promising HIV prevention intervention for these men, and if it is found to be effective, to move it quickly into practice. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS African Americans account for half of all Americans currently living with AIDS, and men account for two- thirds of all African Americans with HIV. African American men who have sex with men and women (AAMSMW) are at particular risk for contracting and transmitting HIV, and represent a priority population for developing effective interventions. Studies of AAMSMW conducted in multiple HIV-epicenters in the United States have reported high rates of unprotected intercourse with male and female partners, concurrent partnerships, and frequent substance use before sex, accompanied by non-disclosure and secrecy regarding sexual risk behaviors. These behavioral dynamics are likely to fuel transmission of HIV and other STDs in diverse sexual networks and communities. Despite the urgent need for effective prevention approaches for AAMSMW, to our knowledge no evidence-based HIV interventions have been developed and tested for this population. We propose to test a behavioral prevention intervention to reduce HIV-related sexual risk behavior among AAMSMW. The intervention, called The Bruthas Project (BP), was designed through four years of formative research with AAMSMW consisting of: (1) qualitative in-depth interviews, focus groups and field ethnography; (2) protocol and measure development; (3) pilot testing and evaluation; and (4) further refinement following process and preliminary outcome data. The BP framework was conceptualized according to ecosocial theory, which emphasizes social and structural inequalities that influence health behaviors, and the BP counseling process was formulated on principles of the Information-Motivation- Behavior (IMB) theory of HIV prevention, and is characterized by an individual-level counseling process that is specifically tailored to recognize the social and cultural contexts that inform sexual behavior for AAMSMW. Delivered in a series of four sessions by trained African American male counselors, the BP focuses on reviewing HIV transmission routes for male and female partners, strengthening sexual communication skills with both male and female partners, and improving condom use skills and other safer sex negotiation strategies. Evidence thus far indicates that BP is an acceptable and feasible model for providing HIV prevention counseling to this population, and pilot outcome data show promising indications of behavior change. A team of trained BP staff have successfully utilized a multi-tiered outreach approach to identify AAMSMW, recruit eligible individuals, and engage and retain participants in a longitudinal evaluation design. A randomized controlled trial (RCT) of BP is necessary to determine the efficacy of the intervention and can lead to improved public health efforts at reducing HIV risk behavior among AAMSMW and in the African American community more generally. We propose the following Specific Aims: 1. To evaluate the effect of a theoretically grounded culturally appropriate intervention on HIV-related sexual risk behavior for African American men who have sex with men and women. 2. To test a theorized mediational process by which participating in the intervention contributes to reductions in sexual risk behavior. 3. To obtain in-depth understandings of the BP intervention implementation processes and experiences at both the organizational and participant level. To achieve these aims, we will recruit and enroll a cohort of 400 AAMSMW who will be randomly assigned to either the intervention condition, in which they will be offered BP, an enhanced four-session individual level counseling intervention, or to the comparison condition, in which they will receive standardized HIV testing and counseling with referral to case management. We will follow the cohort over 9 months and will assess participants at three time points: pre-intervention (baseline), 3 months post intervention (6 months post- baseline), and 6 months follow-up (9 months post-baseline). To augment our understanding of the intervention process, we will collect a qualitative sub-sample, conducting 30 in-depth qualitative interviews with intervention participants, quarterly group interviews with intervention staff, and qualitative data analysis of these data and intervention counseling session notes. If proven effective, BP will establish an evidence-based approach to prevention of HIV acquisition and transmission among AAMSMW, a population that has been notably difficult to reach by public health efforts thus far.